POTENTIAL MUTAGENICITY OF ZDV &NUCLEOSIDE ANALOG IN PERINATAL HIV

To assess the magnitude of difference in the frequency of chromosomal aberrations and mutations in the cord blood of infants who are exposed in utero to ZDV/other nucleoside analogue.